MIND DIET AND DEMENTIA PREVENTION IN ISCHEMIC STROKE PATIENTS

Program Director/Principal Investigator (Last, First, Middle): Morris, Martha Clare and Aggarwal, Neelum T
This is a resubmission of R01 application AG062637 that is retitled to, “MIND Diet and Dementia Prevention in
Ischemic Stroke Patients.” The application is a Phase III randomized-controlled trial designed to test the effects
of a 3-year intervention of the MIND diet plus usual post-stroke care versus usual post-stroke care on cognitive
decline, brain biomarkers of AD and vascular disease, and on functional disability and depression in 500
patients hospitalized for acute ischemic stroke, aged 60-80 years and without dementia who are discharged
home following hospitalization. More than 795,000 people in the U.S. have a stroke every year, the majority of
which (87%) are ischemic. The estimated cost is $34 billion each year. Stroke is the leading cause of serious
long-term disability. It is estimated that about half of survivors will experience cognitive impairment and
depression, and one third will develop post-stroke dementia. Dementia is a major and growing public health
problem that is amplified by the lack of effective cures or therapies to ameliorate the disease progression and
symptoms. Lifestyle modifications, including dietary interventions using the DASH and Mediterranean diets,
have been demonstrated to preserve or improve cognitive function and depression in older adults at high
cardiovascular risk, however, it is unknown whether diet is an effective therapeutic intervention in stroke
survivors. Importantly, dietary recommendations are highly desired by stroke patients and their families. The
MIND diet (Mediterranean-DASH Intervention for Neurodegenerative Delay) is a hybrid of the Mediterranean
and DASH diets but with selected modifications based on foods and nutrients that are important to brain health.
The MIND diet has the same basic components of the DASH and Mediterranean diets, such as emphasis on
natural plant-based foods and limited animal and high saturated fat foods, but uniquely specifies green leafy
vegetables and berries as well as food component servings that reflect the nutrition-dementia evidence. The
trial will employ a parallel group design comparing the effects of the MIND intervention (3 months of delivered
MIND meals followed by dietary counseling) versus usual post-stroke care (3 months of delivered self-selected
meals followed by general stroke health counseling) on decline in cognitive function and functional abilities,
and depressive symptoms. Biological effects of the MIND diet will be assessed by change in measures of
retinal imaging-derived amyloid beta plaque accumulation, and MRI-derived brain macro- and micro-structural
integrity in 300 randomly selected participants. Other biochemical markers will be assessed over the treatment
period in the entire cohort of 500 participants, including: plasma Abeta 42/Abeta 40, brain-derived neurotrophic
factor (BDNF) and plasma markers of oxidative stress and inflammation. In addition, the trial will examine
potential effect mediators and modifiers by a number of cardiovascular risk factors, AD biomarkers, and
biological mechanisms. The proposed study has three recruitment sites at comprehensive stroke centers in
Chicago and one clinical site at Rush University.
PHS 398/2590 (Rev. 06/09) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Morris, Martha Clare and Aggarwal, Neelum Stroke survivors are debilitated by cognitive decline, depression and disability, and pharmacologic treatments are largely ineffective. This application proposes to conduct a Phase III randomized controlled trial designed to test the effects of a 3-year intervention of the MIND diet (Mediterranean-DASH Intervention for Neurodegenerative Delay) on cognitive decline, brain neurodegeneration, functional disability, and depression among 500 ischemic stroke patients, aged 60-80 years and without dementia who are discharged home. The project has great potential to contribute to the NIH mission of funding research that enhances health and reduces illness or disability. PHS 398/2590 (Rev. 06/09) Page Continuation Format Page